Designing supramolecular delivery strategies to understand and exploit synergies in immunoregenerative medicine

ABSTRACT
It remains unclear why some tissue injuries regenerate and heal while others fibrose and scar. It is evident,
however, that the inflammatory response underlies these divergent outcomes. This immune system’s response
to injury depends on a multitude of cell types and organ systems that remain in communication to evolve
collectively, guiding tissue-level outcomes. My lab’s expertise is in the design of local drug delivery systems for
immune modulation. We will leverage these delivery platforms to explore immune systems interactions after local
therapeutic delivery, with applications toward tissue healing and arresting inflammatory disease progression.
Theme 1: How does cell-targeted delivery of therapeutics alter monocyte & macrophage crosstalk?
Macrophages are a primary component of the innate immune system, acting as first-responders to injury and
initiating the activation of other cell types – including their replacement by monocyte precursors recruited from
the bone marrow. Promoting a pro-regenerative macrophage phenotype is a promising therapeutic avenue under
widespread investigation. However, little is known about how macrophage polarization alters monocyte
recruitment and differentiation. This project area builds on my experience in therapeutic macrophage polarization
to develop cell-targeted therapeutics that promote a pro-healing macrophage phenotype at the injury site,
exploring the hypothesis that altered monocyte recruitment and differentiation, not the long-lasting generation of
pro-healing macrophages, is the critical axis supporting an immunoregenerative response. Theme 2: How does
the promotion of early post-injury inflammation alter adaptive immune response? The magnitude and
temporal sequence of cell signals, including chemokines and cytokines, is a critical regulator of cell migration,
differentiation, and polarization; these processes guide evolution of the injury immune microenvironment and
resulting tissue-level outcomes. It has been recently observed that exogenous delivery of inflammatory signaling
promotes tissue healing after ischemic injury. Here, we will explore the hypothesis that beneficial effects result
from the recruitment and differentiation of regulatory T cells by macrophage-derived signals, which can be re-
capitulated by sequential biomolecule release from injectable hydrogels. If successful, this project will elucidate
new design principles for guiding the injury immune microenvironment toward a functional orientation that
supports tissue healing. Theme 3: Can remote drug delivery systems modulate damaging systemic
inflammation? A sequela of dysregulated systemic inflammation often results from significant tissue insults
(heart attack, kidney injury) or chronic inflammatory disease (inflammatory bowel, rheumatoid arthritis). Such
insults are associated with deleterious multi-organ effects, including renal and pulmonary fibrosis,
atherosclerosis, and heart failure. This area of research explores the capacity to develop refillable drug reservoirs
for delivering immunomodulatory drugs to distant immune organs, thereby modulating inflammation at the
primary cell sources.

Public health relevance
NARRATIVE Inflammation is a pervasive driver of disease progression and a crucial mediator of tissue healing processes. This proposal will develop biomaterials that improve our understanding of interactions between different immune system components and recapitulate the progression of signaling mechanisms that underlie normal tissue healing. The work will have broad implications for the development of drug delivery systems and synergistic therapies to treat disease and promote tissue healing.